Pancreatic beta-cell glucose toxicity and mRNA translation

ABSTRACT
Pancreatic β-cells are specialized to carry out high capacity mRNA translation that is tightly regulated by the
nutrient environment. However, these features expose β-cells to several vulnerabilities, including deleterious
endoplasmic reticulum stress and translation errors that can can result in production of defective ribosome
products (DRIPs), which have been implicated in autoimmunity in type 1 diabetes (T1D). Whereas, acute glucose
exposure robustly increases translation of insulin and other secretory granule proteins, chronic high glucose
decreases insulin translation and secretion even prior to impact on global translation or upregulation of
endoplasmic reticulum stress. To determine the extent of translational changes at this early stage of β-cell
dysfunction, I used ribosome profiling and nascent proteomics in MIN6 insulinoma cells to elucidate the genome-
wide impact of sustained high glucose on β-cell mRNA translation. Sustained high glucose conditions that
suppressed insulin secretion downregulated translation of insulin and proteins, such as SCGN, IDH2, VPS41,
SLC2A2, IGF2, SLC30A8 and PFKFB3, which are involved in insulin secretory granule formation, exocytosis,
and metabolism-coupled insulin secretion. Translation of these mRNAs was also downregulated in primary rat
and human islets following ex-vivo incubation with chronic high glucose, and in an in vivo partial pancreatectomy
model of chronic hyperglycemia. Translational downregulation decreased cellular abundance of these proteins.
Subsequent analysis of actively translating ribosomes and pathways that regulate mRNA quality during
translation showed that sustained high glucose changes the protein composition of translating ribosomes and
suppresses nonsense mediated RNA decay (NMD). Altered ribosome composition and activity of RNA decay
pathways could result in changes in the abundance and fidelity of the proteins produced. I hypothesize that
hyperglycemia-induced remodeling of ribosomes and suppression of NMD alter expression of key β-cell genes
and increase neo-antigen production. In this proposal I will investigate the extent to which sustained high
glucose-remodeled ribosomes contribute to dysregulation of mRNA translation in β-cells and determine the
impact of reduced RNA surveillance and altered translation on neoantigen production and autoimmunity in T1D.
These studies could uncover novel therapeutic targets for prevention of progressive β-cell failure in T1D and for
optimizing functionality of ex vivo generated β-cells for cell replacement therapy.

Public health relevance
PROJECT NARRATIVE Failure of pancreatic β-cells to secrete sufficient insulin hormone to regulate blood glucose is a hallmark of diabetes. Early during the development of diabetes, prolonged high glucose levels reduce insulin protein synthesis and may also adversely impact the quality of protein produced. By revealing novel mechanisms through which high glucose regulates insulin protein production and affects quality control during protein synthesis, this study has the potential to identify new targets for treating or slowing down the progression of diabetes.